Discovering Chemical Activity Networks-Predicting Bioactivity Based on Structure

PROJECT SUMMARY
NIEHS has established Predictive Toxicology as a strategic goal for advancing environmental health sciences.
The overarching goal of this RIVER proposal is to predict animal toxicity of chemicals based on their structure.
My team and I will expose millions of zebrafish embryos to a library of 10,000 synthetic chemicals across wide
concentration ranges. If a chemical shows signs of bioactivity, we will systematically analyze whole animal gene
expression changes before the phenotype appears. We will formulate hypotheses about which biomolecular
targets the chemicals attacked initially and which pathways led to the observed endpoint. To test those
hypotheses, we will edit the zebrafish genome via CRISPR/Cas9 to knock out or over-express critical genes, to
discover the ones causally related to the chemical phenotypes.
These studies will be highly relevant to human health. Zebrafish possess fully integrated vertebrate organ
systems that perform the same functions as their human counterparts and demonstrate well-conserved
physiology. Eighty-four percent of the genes that participate in human disease also exist in zebrafish. Zebrafish
studies provide a fast, inexpensive way to screen a large volume of chemicals, generate rich hypotheses for drug
development, and prioritize candidates for toxicity studies with mammals and human cell cultures. We will
compare our results with those of human cell culture studies to clarify the strengths and weaknesses of each
method and to reduce the uncertainty associated with applying zebrafish results to human biology.
We will post our experimental results in a public database that explains which of the 10,000 Tox21 chemicals
are bioactive, which initial targets they strike, and which pathways lead to which endpoints in embryonic and
juvenile zebrafish. This information will enable green chemists to detoxify products by substituting a
biologically inactive molecule. It will help toxicologists and risk assessors to prioritize chemicals for expensive
experiments with rodents and human cell cultures. It will give pharmaceutical scientists thousands of new data
points upon which to develop hypotheses about how to modulate a given gene target or activate a given
pathway.
We will use machine-learning-based chemoinformatic approaches to analyze our zebrafish data and infer the
relationship between the structure of a chemical and its biological activity. Our rich data about chemical
activity networks will advance the scientific community’s understanding of linkages between chemical exposure
and phenotypes. Our work will enable scientists to predict whether a chemical will be biologically active, what
target it will act upon, and what networks it will perturb, solely on the basis of its structure. It will enable
scientists to reduce, refine, and replace experiments with animals, including zebrafish, and to predict chemical
activity networks with computers.

Public health relevance
NARRATIVE We encounter a wide diversity of chemicals throughout our lives, but we are not yet equipped to understand which of these chemicals actually pose health risks. Furthermore, for the chemicals known to produce human disease, we do not fully understand how they lead to adverse outcomes. This project will systematically evaluate the toxicity of thousands of chemicals and discover the biological networks they modulate to help the research and regulatory communities predict the toxicity of relevant chemicals.